Historical social and environmental determinants of memory decline and dementia among U.S. older adults

PROJECT SUMMARY/ABSTRACT
Incidence of Alzheimer’s disease and related dementias (ADRD) is 40–100% higher among Black compared
with White Americans. A key reason for this disparity may include residence in segregated, socially disadvan-
taged, and polluted communities. Extant studies suggest that community socioeconomic deprivation is related
to decreased brain volume, Alzheimer’s neuropathology, and poor cognitive function, and that fine particulate
matter (PM2.5) may contribute to neurodegeneration. Early-life exposures may be particularly important, as
early-life community-level disadvantage and ambient air pollution could disrupt the accumulation of cognitive
reserve, reduce cognitive resilience, and dampen social trajectories. Community-level social factors and air
pollution often co-occur; thus, comprehensive understanding of how these factors operate independently and
synergistically requires rigorous evaluation of both. Moreover, identifying the extent to which these factors
modify underlying genetic risk—APOE-ε4 genotype and ADRD polygenic risk scores—would inform under-
standing of the etiology of ADRD. The overall objective of this application is to evaluate the effects of early-life
community-level social and environmental factors on late-life ADRD and the extent to which these factors con-
tribute to racial disparities on ADRD in a nationally representative sample. The central hypothesis is that early-
life community-level social factors and ambient air pollution have independent and synergistic effects on late-
life brain health and ADRD disparities.
This project leverages the recently completed data linkage between the 1940 census and the national Health
and Retirement Study (HRS) (n≈8,700). Participants in the HRS were an average age of 69 years at first
memory assessment between 1995–1998, so HRS includes up to 23 years of longitudinal data on memory
scores and dementia, and a subsample also has genotype information. The central hypothesis will be tested in
four specific aims among Black and White HRS participants: (1) Investigate the effects of early-life community-
level social factors on late-life cognitive health; (2) Examine the effects of early-life ambient air pollution expo-
sure on late-life cognitive health; (3) Estimate synergistic effects of early-life community-level social factors and
air pollution exposure on late-life cognitive health; and (4) Evaluate the extent to which early-life community-
level social factors and exposure to ambient air pollution modify effects of ADRD genetic risk on late-life cogni-
tive health. The proposed research is innovative because it assesses joint early-life social and environmental
community-level exposures, including via novel air pollution metrics and late-1930s redlining, for ADRD. The
proposed work is expected to advance the field by providing new policy-relevant evidence on potential strate-
gies to prevent ADRD and eliminate ADRD disparities.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease and related dementias (ADRD) are a major public health problem, and evidence suggests experiences and the environment in early life might play an important role in development of ADRD. ADRD dis- proportionally affects Black and socially disadvantaged Americans, and our study assesses early-life social disadvantage including systemic racism and ambient air pollution as modifiable determinants of ADRD. Study results have the potential to identify key modifiable factors that affect ADRD and explain ADRD disparities.